Administrative Core

Project Summary – Administrative Core
The Administrative Core will oversee the daily running of all resource core components and their staff, and
administer the Core research grant. An Advisory Group, consisting of the PI and the Directors and
technicians of each Resource Component, will meet on a 3-monthly basis to discuss any issues related to
the Core instruments, technical support and overall usage. This advisory group will consult with an External
Advisory Group, made up of highly-respected vision researchers who are directors of components of the NEI
core grants held at their respective institutions, in California. Mechanisms to optimize usage and productivity
by the core investigators will be addressed regularly. Information on the instruments and services available
from the Resource Components are available on a newly-established web site. Investigators schedule their
usage of Core facilities, through a secure link from the website. All usage is thus recorded in electronic log
books. Administration of the Core grant, with respect to accounting and reporting will be performed by a
Grant's Analyst, in coordination with the PI.